Investigating the structure and function of the human centromere and kinetochore

Project Summary
Accurate segregation of chromosomes during cell division is one of the most fundamental requirements in
biology. Without proper chromosomal segregation, genetic information cannot be faithfully transmitted across
cell and organismal generations, leading to severe consequences including cell death, developmental defects,
or progression of cancer. Furthermore, improper chromosome segregation in cancer cells has been shown to
lead to anti-tumor inflammatory responses. Central to the process of chromosome segregation is the centromere,
the chromosomal locus at which spindle microtubules bind. The centromere is defined epigenetically by the
presence of nucleosomes containing the histone variant CENP-A. Centromeric chromatin serves as the
foundation of the kinetochore, a large protein complex which assembles on CENP-A nucleosomes and mediates
microtubule binding. Research into the centromere is necessary to better understand the processes that underlie
chromosome segregation in both health and disease, but our understanding of the human centromere remains
largely incomplete. This proposal aims to answer fundamental questions about the structure and function of the
centromere and its associated proteins. Recent advances in reconstitution of large centromeric protein
complexes have increased our understanding of the structure of the human kinetochore, but reconstituted
complexes can only approximate in vivo structures, and currently there are multiple competing models for the
structure and organization of the centromere and kinetochore. The emerging technology of cryo-electron
tomography (cryo-ET) provides the opportunity to interrogate the structure of the centromere and kinetochore in
their native context within vitreous hydrated cells. To this end, in Aim 1 cryo-ET will be used to obtain the first in
situ structures of the human centromere and kinetochore in the interphase and mitosis stages of the cell cycle.
The second focus of this proposal is to elucidate the interactions among centromeric proteins that are required
for the essential functions of the centromere, including formation of microtubule attachments and maintenance
of centromeric identity. Two kinetochore proteins, Ndc80 and CENP-Q, have both been shown to contribute to
microtubule binding in vitro and in vivo, but their respective roles in microtubule binding in vivo have not been
fully characterized. Multiple proteins within the constitutive centromere-associated network (CCAN) have
similarly been shown to contribute to maintenance and deposition of CENP-A at the centromere, but the CCAN
contains multiple interconnected subcomplexes whose contributions have never been systematically tested. In
Aim 2 mutagenesis of the respective endogenous gene loci (and rapid depletion of the respective wild type gene
products) will be used to elucidate in vivo and with temporal accuracy the interactions that underlie spindle
attachment and maintenance of centromeric identity. These experiments will provide important insights into the
structure and function of the human centromere and kinetochore which are essential for proper chromosome
segregation and genomic fidelity across generations.

Public health relevance
Project Narrative The centromere, the chromosomal locus at which the kinetochore protein complex assembles and mediates attachments to spindle microtubules, is essential for proper segregation of chromosomes and therefore faithful propagation of genetic information across cell and organismal generations. Aberrant chromosome segregation contributes to cancer progression, leads to developmental defects, and activates anti-tumor inflammatory responses. This application proposes to obtain the first in situ structures of the centromere and kinetochore and to answer fundamental questions about the protein interactions required for essential centromere functions.